Development of a Predictive Frailty Clock & Longitudinal Investigation of its Epigenetic Determinants

Project summary/abstract
Longevity studies in mice are expensive and time-consuming, and there are currently no
measures that can predict mortality in a mouse at an earlier time-point. Additionally, there are
very few measures of the overall health of mice that can be assessed longitudinally. In
humans, frailty can predict mortality with greater power than the DNA methylation clock. In my
early postdoctoral work I have validated a mouse frailty index, that increases with age, is
associated with mortality and age-related pathologies, and is sensitive to interventions. In the
Sinclair lab I have used machine learning modelling of this mouse frailty index to make the
Analysis of Frailty in Death (AFRAID) clock that can predict the lifespan of male C57BL/6 mice
aged 21 months or older with accuracy of approximately 1.7 months. We hypothesis that a
frailty clock that includes a range of measures including physiological and molecular measures
(blood-based Analysis of Frailty in Death, bAFRAID) will accurately predict lifespan in younger,
female mice of a different strain. To test this hypothesis I will complete a battery of health
assessments, including blood collection for novel peptide biomarker detection, in male and
female UM-HET3 mice every 3 months from 15 months of age until death. I will use regression
modelling of all measured outcomes to develop an optimized `bAFRAID clock' that predicts
time to death in mice. I will complete this part of the project at Harvard Medical School in the
lab of Dr David Sinclair, who will act as my mentor and is an internationally recognised expert
in the biology of aging. I will receive additional training in biomarker modelling and peptidomics
from experts Drs Steve Horvath and Steve Gygi. For the independent phase of this award, I
will use longitudinal assessments, and cutting-edge epigenetic tools to investigate the
relationship between epigenetic changes and the AFRAID clock. This will increase our
understanding of whether epigenetic mechanisms underly the onset of frailty in aging. The
completion of this project and the proposed training will position me in an ideal position to
achieve my career goal of becoming an independent researcher with a lab focused on
understanding the mechanisms of frailty in aging.

Public health relevance
Project Narrative This project aims to develop a new tool to assess the overall health of a mouse and predict early in a mouse's life when it will die. This assessment will be an important tool for the aging research field to increase the efficiency of studies looking at interventions to delay aging.